Development of a Novel Class of Antifungal Therapy

Development of a Novel Class of Antifungal Therapy: This project aims to address the
urgent need for new antifungal treatments by developing a novel class of small molecules with
potent activity against drug-resistant fungal strains. Using proprietary chemical structures, SHY
Therapeutics will identify and optimize compounds for clinical use, focusing on efficacy, safety,
and overcoming current treatment limitations.
Fungal infections affect millions of people each year, posing a significant global health
burden. Existing antifungal therapies are often inadequate due to drug resistance, toxicity, and
insufficient efficacy, particularly in immunocompromised populations. To tackle this challenge,
SHY Therapeutics has developed a wide range of new and proprietary chemical structures, with
preliminary screening identifying novel compounds active against Cryptococcus neoformans,
Candida auris, Candida albicans, and Candida parapsilosis.
In this Phase 1 proposal, we aim to identify novel classes of small molecules to be
optimized for anti-fungal therapy through 3 aims: Aim 1 of this project is to use a Structure-Activity
Relationship (SAR) approach to optimize anti-fungal activity of newly synthesized compounds,
focusing on Candida auris and Cryptococcus neoformans. The most active compounds will
undergo further testing against a panel of over 50 fungal strains, including drug-resistant variants,
and will be evaluated for ADME/PK properties and in vivo efficacy in murine infection models. Aim
2 focuses on identifying the protein targets interacting with and inhibited by the identified small
molecules using Drug Affinity Responsive Target Stability (DARTS), followed by development of
cell-free assays to gain insights into the mechanism of action of the identified small molecules.
Aim 3 involves conducting a proof of concept in vivo efficacy study in a murine disseminated
candidiasis model, prioritizing a promising hit compound, SHY-4.
SHY has a successful track record in the design, synthesis and testing of novel compounds
in other therapeutic areas, resulting in 10 issued patents to date. SHY Therapeutics has already
identified compounds with strong antifungal activity and minimal impact on mammalian cell
viability, suggesting a potentially superior safety profile compared to current FDA-approved drugs.

Public health relevance
Project Narrative: Treatment resistant fungal infections, particularly in immunocompromised patients, pose a significant global health challenge. We propose here to develop a class of small molecules as novel antifungal therapies. This proposal outlines a comprehensive approach, including compound optimization through structure-activity relationship (SAR) analysis, target identification, and in vivo assessment to optimize these molecules for potential clinical use against drug-resistant fungal infections.